Mechanisms controlling microtubule organization during cell differentiation

PROJECT SUMMARY/ABSTRACT
The microtubule cytoskeleton is a critical regulator of cell differentiation and must be spatially organized by
subcellular sites called microtubule organizing centers (MTOCs) to fulfill cellular functions. Since the discovery
of MTOCs over 50 years ago, the majority of MTOC research has focused on the centrosome, an organelle
that organizes microtubules during animal cell mitosis. However, MTOC function is reassigned to non-
centrosomal sites during cell differentiation: non-centrosomal MTOCs (ncMTOCs) form at the apical membrane
of epithelial cells, the axons and dendrites of neurons, and the nuclear envelope in skeletal muscle cells, and
non-centrosomal microtubules are critical for the development and function of the tissues that these cell types
comprise. The generation of non-centrosomal microtubule networks is associated with the simultaneous
inactivation of MTOC function at the centrosome and defects in centrosome inactivation are prevalent in
epithelial cancer and linked to invasive cell behavior. Thus, a dramatic reorganization of the microtubule
cytoskeleton is a fundamental aspect of cell differentiation, and my lab has used support from NIGMS over the
last 5 years to uncover mechanisms of ncMTOC establishment and centrosome inactivation. We established
C. elegans as an in vivo model of non-centrosomal microtubule organization, identifying and characterizing
ncMTOCs at the apical surface of intestinal epithelial cells and at the tips of the dendrites in sensory neurons.
By developing tools for tissue-specific degradation and proximity labeling, we found that essential MTOC
proteins can vary across subcellular locations and cell types and identified novel ncMTOC components,
including the spectraplakin protein VAB-10B and primary microcephaly protein WDR-62. We uncovered the
modes and mechanisms by which MTOC function is removed from the centrosome and identified an essential
SPD-5-based module of proteins required for centrosomal MTOC function across cell types. With these
technical and conceptual advances in hand, our goal over the next 5 years is to answer fundamental questions
related to microtubule organization: 1. How do differentiated cell types build specialized microtubule
networks? We will use VAB-10B and WDR-62 as genetic handles to define comprehensive proximity maps of
ncMTOCs across cell types with the goal of understanding how ncMTOCs first arise during differentiation; 2.
How and why is MTOC function inactivated at the centrosome? We will uncover the molecular mechanism
by which SPD-5 transforms the centrosome into an MTOC and test the physiological relevance of centrosome
inactivation; 3. How do compound microtubules form? Using novel genetic tools, we will determine how
microtubules build onto one another to form doublet microtubules, conserved features of organelles called cilia.
These questions are fundamental to our understanding of cell differentiation and leverage unique properties of
C. elegans to address this important, but understudied topic in cell and developmental biology.

Public health relevance
PROJECT NARRATIVE All animal cells use microtubules during division to create the mitotic spindle and during differentiation for cell polarity, shape, and transport. The proposed research will define the mechanisms that control how microtubules become spatially organized to carry out these fundamentally different processes. An understanding of the mechanisms that control microtubule organization should provide therapeutic insight into the growing number of specific birth defects and human cancers that have been linked to defects in the microtubule cytoskeleton.